Single Cell Analysis Core (Core C)

PROJECT SUMMARY/ABSTRACT - CORE C: Single-Cell Analysis Core
HR arises from cell-to-cell variation of genotypic and metabolic processes. The goal of the Single-Cell Analysis
Core (Core C) is to provide experimentally-validated and yet difficult-to-perform single-cell-level analyses to
evaluate the mechanisms and dynamics of HR. Core C will support the single-cell-level studies proposed in all
three Projects by providing a centralized platform for culturing bacterial cells under well-controlled antibiotic
environments, measuring relevant processes at single-cell resolution, and performing image analysis as well as
necessary statistical analysis. Specifically, Core C will i) provide microfluidic continuous culture platform, ii)
quantify the copy number variation of resistance genes, and iii) determine metabolic activities of single cells in
heteroresistant populations. Core C activities will be conducted by Dr. Minsu Kim's laboratory in the Department
of Physics at Emory University, which has extensive expertise in single-cell-level imaging and analysis of gene
expression, metabolism, and physiology in bacteria. Dr. Kim was one of the first scientists to apply a single-cell
approach to antibiotic research and is considered a leading expert in this area. Dr. Kim and his team will work
with the PI of individual projects collaboratively to ensure they can successfully complete their projects in a timely
manner.

Public health relevance
PROJECT NARRATIVE In accordance with RFA-AI-20-001, the project narrative should not be completed for the scientific core.